Ethical Implementation of Social Epigenomics Research on Asthma in a Health Disparity Population

SUMMARY
Asthma is the most common chronic childhood condition and exacerbations are often linked to a rhinovirus
infection. Asthma shows significant health disparities, with greater prevalence and morbidity in African American
children than in white non-Hispanic children, but the underlying causes of this disparity is not well understood.
Our ongoing parent award, abbreviated as the “Stress, Epigenomics and Asthma” (SEA) study seeks to explore
a mechanism for previously published links between chronic stress experienced by racial minorities and asthma
risk and morbidity through studying the impacts of chronic stress on epigenomic changes affecting immune
response to viral infections such as rhinoviruses. Unraveling the mechanism by which chronic stress may alter
immunity and, in turn, asthma risk offers potential targets for the development of precision medicine interventions
that could address health disparities. Yet, the linking of negative social experiences to biological changes,
particularly in a population that already experiences racism holds potential psychosocial risks for participants
and risks of unintended group harm to a vulnerable population. This supplement proposes to add a bioethics
research component to the SEA study to explore the unique bioethical issues in the emerging field of social
epigenomics. In-depth interviews with parent participants in the SEA study will explore participant experiences
with the study and their attitudes about social epigenomic research in asthma and beyond. The study of reasons
eligible families decline participation in the SEA study will further explore concerns about the research in the
eligible study population. Additionally, focus groups held with members of the African American community will
use the parent award as an example to investigate attitudes in this historically marginalized community about
social epigenomics, potential benefits and risks of this line of research, and strategies for minimizing risks of
unintended population group harms. This supplement will support bioethics research on social epigenomics
investigations to provide an evidence base to inform future policy around ethical issues including informed
consent, the collection and linking of sensitive social and genomic information, and dissemination of findings
through publication and data sharing in ways that protect vulnerable populations.

Public health relevance
NARRATIVE Asthma is the most common chronic disease of childhood and disproportionately impacts African American children. Our parent award studying potential links of chronic stress to biological changes in immunity impacting asthma risk and morbidity in African American children holds promise for new precision medicine therapies, but also risks of increased stigma and stereotyping in a historically marginalized community. This supplement will explore perceptions of social epigenomics research and strategies to minimize risk through qualitative interviews and focus groups with African American participants in our study of social epigenomics of asthma and community members, respectively.